Frailty and Resiliency in Older Adults with Acute Myocardial Infarction

The purpose of this research is to support the development of Dr. Abdulla Damluji into an
independent investigator focused on studying geriatric syndromes during cardiovascular intervention.
The K23 award will allow the development of a fundamental skillset including: the design and methods for
analysis of interventions, understanding and proper application of frailty and resiliency assessments, designing
pilot prospective studies, and enhancing knowledge of geriatrics and gerontology. Skills will be obtained through
coursework, workshops, seminars, scientific meetings and mentored research. The overall goals are: 1) identify
a simple universal bedside frailty test for clinical decision-making and 2) become an NIH-investigator prepared
to conduct a clinical trial aimed to evaluate the comparative effectiveness of different treatments of acute
myocardial infarction (AMI) in a heterogenous population of older adults living with frailty and lack of resiliency.
Two thirds of all patients with cardiovascular disease (CVD) are older than 60 years of age, and >85% of
patients over age 85 years live with some form of CVD. Of those older patients admitted with acute AMI, a
majority experience frailty, a syndrome of decreased physiologic reserve and vulnerability to stressors.
Moreover, some of these frail patients lack physical resiliency, the ability to rebound back and recover from a
major health crisis. Critical “gaps in knowledge” in cardiovascular care for older adults, particularly those with
frailty and lack of resiliency, have been identified. These “gaps” need to be addressed in order to provide the
best possible care to a growing older patient population. This proposal examines the hypothesis that frailty
and resiliency influence the treatment choice and health outcome after AMI. Aim1 evaluates the
prevalence of frailty in U.S. among older AMI patients by treatment [percutaneous coronary intervention (PCI),
coronary artery bypass graft (CABG) surgery, or guideline-directed medical therapy (GDMT)] using the validated
claims-based frailty index. Aim 2 examines the role of frailty in treatment response to PCI and CABG. Aim 3
validates the diagnostic accuracy of a bedside 4-item frailty scale and assesses whether this diagnostic tool,
used in combination with resiliency measurements, can predict health outcomes at 1-year follow-up.
The institutional environments at both the Inova Heart and Vascular Institute (IHVI) and Johns Hopkins
University (JHU) are ideal for conducting cardiovascular outcomes research. The mentorship consists of leaders
with expertise directly relevant to the career goals of the applicant: Christopher M O’Connor, MD (IHVI; expert
in experimental design); Dr Wayne Batchelor (IHVI: interventional cardiologist); Jodi B Segal, MD, MPH (JHU:
internist/epidemiologist; expertise in clinical effectiveness), and Gary Gerstenblith (JHU: geriatric cardiology).
Resources at IHVI include bioinformatics laboratory, grant management office, and a state-of-the-art research
office. At JHU, resources include the Bloomberg School of Public Health, Graduate Training Program in Clinical
Investigation, JHU Pepper Center Biostatistical and Research Education Cores, and the Welch Medical Library.

Public health relevance
PROJECT NARRATIVE More than two-thirds of older adults are living with symptomatic cardiovascular disease. Many live with undiagnosed geriatric syndromes including phenotypic frailty and lack of physical resilience. This research proposal will enhance our understanding of the influence of geriatric syndromes on health outcomes, disability, and health-related quality of life among older adults with acute myocardial infarction.